Cellular Basis of Novel Organelle Integration by a Photosynthetic Animal

PROJECT SUMMARY / ABSTRACT
Endosymbiotic events have driven the evolution of dramatic and consequential biological traits, however most
known examples occurred billions of years ago, resulting in deeply integrated associations that mask early steps
in the evolution of these associations. “Solar powered, sap sucking” Sacoglossan sea slugs represent a recent
and incompletely established endosymbiosis in which stolen, functional chloroplasts are stored in slug tissues.
Here, I propose to leverage this unique organism to understand the mechanistic basis of stolen chloroplast
(kleptoplast) retention and integration into host cell physiology as a model for understanding endosymbiosis
more broadly. To accomplish this, I will: (Aim 1) use organellar proteomics to identify proteins critical for
establishment and maintenance of this endosymbiosis (often called “functional kleptoplasty”), (Aim 2) determine
the function of those proteins using a combination of pharmacology, patch clamp experiments, and heterologous
expression studies, and finally (Aim 3) expand these experiments in a comparative approach using different
species of Sacoglossan slugs with different retention abilities. Thus, this study will employ rigorous methodology
combining state-of-the-art sequencing technology and multi-omics approaches with physiological approaches,
functional assays, and a diverse set of imaging techniques. Further, I will leverage the incredible biodiversity of
sea slugs to empower a comparative approach for a comprehensive understanding of a truly unique biological
phenomenon: the maintenance of functional photosynthetic chloroplasts within animal tissues. This project will
take place at host institution Harvard Medical School (HMS, Cell Biology) and builds on my expertise in
transcriptomics, evolutionary biology, and bioinformatics with training in new skills from my primary sponsor, Dr.
Corey Allard (HMS, Cell Biology), in electrophysiology, biochemistry, and molecular techniques. I will be aided
by an interdisciplinary advisory team composed of my co-sponsor, Dr. Wade Harper (HSM, Cell Biology), an
expert in organelle proteomics, Dr. Steven Gygi (HMS, Cell Biology), a world leader in proteomics, and Dr. Amy
Lee (HMS, Cell Biology/Dana Farber Cancer Institute), an expert in transcription and RNA biology. Investigation
of functional kleptoplasty in Sacoglossan sea slugs will fill a critical gap in our understanding of the evolution of
endosymbiosis and the integration of novel organelles into host cells. Completion of these aims will reveal
mechanisms used by slugs for sequestration and maintenance of chloroplasts, and thus advance our
understanding of the origins and functions of organelles and the fundamental processes that drive the evolution
of novel traits. These insights may have broad applications in biotechnology, and could serve as a blueprint to
engineer other types of cells to perform photosynthesis, or to take up different foreign cargoes for applications
in agriculture, medicine, or even space travel.

Public health relevance
PROJECT NARRATIVE Sacoglossan sea slugs have the remarkable ability to steal and sequester functional algal chloroplasts to perform photosynthesis in their own cells. Studying this poorly understood phenomenon will provide a unique approach to understanding the origins and functions of novel organelles and could serve as a blueprint toward engineering other cell types to take up and maintain foreign cargoes for a diversity of applications including medicine and agriculture. To accomplish this goal, we will exploit the natural diversity of slugs which retain stolen chloroplasts for different lengths of time, and combine transcriptomics, proteomics, pharmacology, and cell physiology techniques to understand the molecular basis of organelle theft and retention in these animals.